Community Outreach and Engagement

PROJECT SUMMARY/ABSTRACT (COMMUNITY OUTREACH AND ENGAGEMENT)
The Rogel Cancer Center (Rogel) Office of Community Outreach and Engagement (COE) broadly supports the
center’s mission to reduce the burden of cancer and advance health equity in our catchment area (CA) via
transdisciplinary research, education, patient care and community outreach. Rogel COE leads all aspects of the
center’s COE efforts, including strategic planning, establishing and propelling the specific aims, launching new
initiatives and evaluating the impact of COE activities. During the last period, Rogel expanded its CA to the entire
State of Michigan. The decision to expand the CA is aligned with an expanded University of Michigan (U-M)
clinical enterprise as well as new collaborations with Middle Eastern and North African (MENA) communities and
partnerships with rural and Native American populations outside of our prior CA, along with new community-
based research and intervention activities across the full State. The decision on expansion was also based on
input from the Rogel Community Advisory Board (RCAB) and External Advisory Board (EAB). Our statewide CA
comprises ~10 million residents (versus 5 million in the prior CA), who are more diverse than those of the prior
CA; now 76% White and 14% Black compared to 84% White and 9% Black, previously. The statewide CA also
has a higher percentage of Hispanic residents – 5.6% now compared to 4% previously – and the percent of
Native American (<1%) and Asian (~3%) residents remains the same. Overall, age-adjusted cancer mortality
rates are higher in Michigan than the US (166/100,00 vs. 156/100,000), with Michigan ranked 13th worst in the
country for cancer mortality. We have identified key behavioral risk factors along with nine priority cancers that
inform and shape our goals for impact and our research, training, education, and outreach efforts. The risk factors
are: colorectal cancer screening, cigarette and alcohol use, physical activity and obesity, and poor mental and
physical health. The priority cancers are: bladder, breast, colon, liver, lung, myeloma, prostate, pancreas and
uterine cancer. The Rogel COE has four main specific aims: 1) Describe the CA and its population; 2) Define
the cancer burden and priority cancers in the CA; disseminate this information within the Rogel and broadly
across our CA in partnership with our Community Advisory Board and key organizations across the state; 3)
Drive and support Rogel programmatic research as well as education efforts to address CA priority cancers and
risk factors; and 4) Conduct education and service programs that meet the needs of our CA residents and
address key disparities in incidence, mortality and risk factors.